Hybrid E-zine Health Education intervention integrated within a Mental Health package for Adolescent Perinatal Depression (E-zineMH)

Abstract
High temperatures in tropical regions could increase mental and physical health complications of
perinatal adolescents and their infants, increasing their risks of depression and adverse obstetric
complications such as miscarriages, preterm birth, low infant birth weight and still births. The United
Nations recommend health education integrated within collaborative health packages in antenatal
clinics to address the impact of climate change. Barriers to implementing environmental health care for
the perinatal population as part of integrated packages in primary care in Nigeria are high at the needs
(context-relevant), service(capacity of providers), and consumer awareness (uptake of services) levels.
This application builds on the evidence and lessons learned from previous work on perinatal
adolescents and ongoing K43 award PI (Dr. Kola's-K43TW011046-4) in Nigeria on, mhGAP -perinatal
depression integrated model within primary care, mHealth and technology strategy testing, and
implementation system development research. As part of a K43 emerging global leader award, we
designed and developed a self-management mobile phone application as an adjunct treatment and
part of a hybrid (face-to-face + mobile phone follow-up care) intervention for perinatal adolescents to
promote positive mental and physical health behavior using age and culturally appropriate
approaches.
The perinatal adolescents who participated in the trial and their caregivers so far have reported high
levels of satisfaction with the intervention. Our experiences identified the vital role of family members
and other caregivers (who are often too busy to regularly accompany their wards to the clinics on
antenatal days) in service designs for this population. We are now
proposing to further leverage virtual
space and vital role of family members to deliver a Hybrid E-zine health education intervention
integrated within a Mental Health package for perinatal depression (
E-zineMH)
, to minimise the
possible impact of climate change in the perinatal population. In
Aim 1, we will develop an Health
Educational Intervention of health promotion and disease prevention services on climate change for
the use of perinatal adolescents and their caregivers. The intervention will be delivered through E-zine
photos and face to face health education, within an existing integrated mental health (E-zineMH)
model in primary care. Aim 2. We will study the feasibility, acceptability, and usability of E-zineMH in a
pilot trial among perinatal adolescents and their caregivers in comparison to a control arm that delivers
face to face health education in routine antenatal clinics. The findings from this study will provide
actionable evidence for technology approach for Health Education Intervention service set-up in
primary care in the perinatal adolescent population for testing in a larger study.

Public health relevance
Narrative Barriers to implementing a health intervention for climate change in the perinatal population as part of integrated packages in primary care in Nigeria are high at the needs (context-relevant), service(capacity of providers), and consumer awareness (uptake of services) levels. We will leverage virtual space and vital role of family members to deliver a Hybrid E-zine health education intervention integrated within a Mental Health package for perinatal depression ( E- zineMH) , to minimise the possible impact of climate change in the perinatal population. Successful completion of the work provide actionable evidence for technology approach as basis for a future larger study